Best Evaluation Tools & Techniques for Effective Recommendations for Policies

DESCRIPTION (provided by applicant): PROJECT SUMMARY/ABSTRACT A major problem with the development and implementation of potential solutions for preventing or decreasing childhood obesity is how to evaluate those solutions while accounting for the many confounding and contextual factors that may affect program delivery or impact. Community-based childhood obesity programs have been shown to be effective for some behavioral or health outcomes, yet childhood obesity remains prevalent and a leading public health concern. Few studies have evaluated multilevel, multi-sector programs that induce the environmental and policy changes thought to be required to impact childhood obesity. Virtually none have reported feasibility, cost-effectiveness, efficiency, scalability, and sustainability estimates for implementing programs on a national scale. The Best Evaluation Tools & Techniques for Effective Recommendations for Policies (BETTER Policies) project will serve as the independent evaluation center for three childhood obesity demonstration projects. The aims of the BETTER Policies project are to: assist the three DP in identifying assessment methods and tools; design a comprehensive evaluation plan in collaboration with the projects and CDC; serve as the central data repository; conduct an impact evaluation to assess process and outcomes of the projects; disseminate information and recommendations to decision-makers and the public; develop an evaluation toolbox that can be used in future program evaluations. Our complex evaluation design will identify and test causal relationships linking environmental and institutional (e.g., healthcare system, schools, childcare) interventions with changes in determinants leading to changes in health-related behaviors and outcomes. In addition, we will evaluate the delivery, effectiveness, feasibility, and sustainability of program activities. We have developed innovative approaches for collecting, combining, and interpreting information from multiple projects to identify causal and contextual factors affecting program delivery and outcomes. The results will be used to make evidence-based recommendations to inform decision-making about implementing the programs in broader populations and contexts, including potential site-specific program alternatives or modifications based on community characteristics. We will produce a publicly available evaluation toolbox with methods and techniques that are matched to the elements in the CDC Framework for Program Evaluation in Public Health. Finally, we will disseminate the information gained and lesson learned to policy makers and the general public in formal reports and briefs as well as a variety of multimedia products (Web sites, social media sites and links, radio and television public service announcements, etc.).

Public health relevance
PROJECT NARRATIVE A major problem with the development of potential solutions for preventing childhood obesity is how to evaluate those solutions while accounting for the many confounding and contextual factors that affect program delivery or impact. The Best Evaluation Tools & Techniques for Effective Recommendations for Policies (BETTER Policies) project will conduct a comprehensive evaluation of three complex community-based childhood obesity programs to determine their effectiveness, feasibility, and sustainability. Results from this project will be used to make evidence-based recommendations that are relevant to decisions and policies for implementing the programs or program components nationally. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Obesity is a well-recognized and long-established problem that has no proven large-scale, sustainable solution. Childhood obesity in particular has complex determinants, involving biological, behavioral, sociocultural, and environmental factors spanning multiple societal levels. A major problem with the development and implementation of potential solutions for preventing or decreasing childhood obesity is how to evaluate those solutions while accounting for the many confounding and contextual factors that may affect delivery or impact of program interventions and activities. Studies or programs that target only the child or family fail to address the complex, interactive nature of childhood obesity within the complex, multifaceted context of modern society and culture. The Best Evaluation Tools & Techniques for Effective Recommendations for Policies (BETTER Policies) project is an evaluation plan that incorporates the complexities involved in investigating childhood obesity into the design, analysis, and interpretation of the three childhood obesity Demonstration Projects (DP) funded through this cooperative agreement. Our evaluation will define and test causal paths linking environmental and institutional-level interventions with changes in determinants that lead to changes in health-related behaviors and outcomes. We have developed a complex evaluation design for this project using innovative approaches for combining and interpreting information from multiple projects. This process will result in identifying important contextual factors that affect delivery or outcomes and making recommendations to inform policy for national implementation of effective childhood obesity programs. In addition, we will produce an evaluation toolbox with methods and techniques that are matched to the conceptual elements in the "Framework for Program Evaluation in Public Health" [1]. This toolbox will be made publicly available so it can be used to evaluate future projects that aim to produce recommendations to inform policy. We have a strong multidisciplinary team which is already in place, has a history of collaboration, and is ideally suited to plan and conduct this complex evaluation. Team members include experts in measurement, evaluation, statistics, social and clinical psychology, counseling, social work, engineering, geographic information systems, kinesiology, nutrition, health, economics, pediatrics, and primary care. The BETTER Policies team has wide, cross-disciplinary expertise and experience. The team members are affiliated with one or more centers at the University of Houston that will be participating in and supporting this project, including the Texas Obesity Research Center (TORC), the Texas Institute for Measurement, Evaluation and Statistics (TIMES), the Texas Learning and Computation Center (TLC2), the Laboratory of Integrated Physiology, and the Center for Neuromotor and Biomechanics Research. These centers have extensive technical and professional expertise, administrative support services, ample data storage capacity, abundant computing power, state of the art software, and proficiency in managing and securing large amounts of data across multiple sites, as well as existing research-related networks and affiliations, including a number of community- based consortiums focused on obesity and childhood obesity. As such, our team at the University of Houston has "quick-start" capacity to perform as Evaluation Center component of this cooperative agreement. Aims 1. Advise and assist the three DP in identifying common assessment methods and tools. 2. Design an evaluation plan for each DP and for a cross-site, aggregate assessment. 3. Serve as the data repository for the entire initiative. 4. Conduct an impact evaluation to assess process and outcomes within and across the three DP. 5. Report and disseminate information and recommendations. a. Provide reports and recommendations to inform policy and decision-making relative to the effectiveness, feasibility, and sustainability of the activities demonstrated in the DP. b. Provide and disseminate evidence-based, validated information including formal reports and briefs, scientific publications, media releases, and multimedia products (Web sites, social media sites and links, radio and television public service announcements, etc.). 6. Develop and disseminate an evaluation toolbox that will serve as a guide for designing and conducting an evaluation that compares multiple complex public health programs.